Modulating cortical inhibitory networks to improve stroke recovery

The overarching goal of this project is to identify new targets for neural circuit modulation to
facilitate motor recovery after stroke. To accomplish this, I propose to identify how dynamics in a
specific inhibitory cell network participates in motor learning, investigate how these dynamics are
disrupted by stroke, and test whether their modulation can improve recovery. Completion of this
project will provide me with opportunities to fill key gaps in my current skillset and equip me to
launch an independent research program in the neurophysiology of recovery. I have carefully
designed a career development program to address these training gaps through a combination
of hands-on experimentation, coursework and didactics, and mentorship from an exemplary team
of physician scientists at the San Francisco VA and UCSF. My mentorship team has a strong
record of training and developing young investigators; together with the rich research environment
at the San Francisco VA, I will be well-equipped to accomplish my outlined training goals. The
results from these experiments will lead to publications and pave the way for many important lines
of investigation I will pursue in my own laboratory.

Public health relevance
Roughly 6,000 new cases of stroke are admitted to the VA hospital system each year, and over half of these patients will experience long-term disability. Neuromodulation is a promising treatment avenue for enhancing recovery from stroke, but current approaches are limited by a limited understanding for how external stimulation interacts with brain dynamics. Here, I propose to (1) study how dynamics in a specific inhibitory network supports motor learning and recovery and (2) probe the impact of activating these inhibitory networks on learning and recovery. My goal is to discover fundamental principles for neural circuit plasticity that can be translated into more effective neuromodulation therapies for stroke patients.